CORE C (Biostatistics and Bioinformatics Core)

CORE C - SUMMARY/ABSTRACT
The Biostatistics and Bioinformatics Core (BBC) is designed to provide professional expertise in
biostatistics and bioinformatics for all P01 projects, investigators, and participants. Core personnel have and will
continue to work closely with project and core leaders to ensure the core provides state-of-the-art biostatistics
and bioinformatics support. The BBC support is required in all P01 studies. Core services include experimental
design development, data quality control, statistical analysis and interpretation of findings, and collaboration on
presentation of results. The core director, biostatisticians, and bioinformaticians are readily available to
investigators and maintain regular contact with project and core leaders. Functions provided by this core include
development of experimental designs, power analysis, and sample size estimation; data quality control;
statistical/bioinformatics analysis and interpretation of findings; collaboration on presentation of results; and
development and evaluation of statistical methods for experimental design and data analysis. To achieve these
functions, the core director and core members are constantly available to investigators and are in regular contact
with the P01 Leader, Project Leaders, and Core Directors.

Public health relevance
Narrative The purpose of the Biostatistics and Bioinformatics Core (Core C) is to provide professional expertise in computing, bioinformatics, and biostatistics for all P01 projects, investigators, and participants.